Administrative Services

CORE C: ADMINISTRATIVE SERVICES The purpose of this core is to provide administrative services to all investigators of the Program Project. The services are provided by staff members of the Transplantation Biology Program and include general secretarial support, word processing, meeting organization and documentation, budgetary management, and financial monitoring to ensure that usage of grant funds is efficient and in compliance with federal guidelines. The core will organize the annual meeting of the outside advisors and the meetings of the consortium members.